Whole Blood Point of Care Metabolic Measurement - SB1

PROJECT SUMMARY
Persons of all ages with certain metabolic disorders are at-risk for metabolic crises when a certain
metabolite accumulates in the blood. While this metabolite can be measured in a clinical laboratory, currently
there is no home-based device to monitor the metabolite that causes the metabolic crises.
Patients, their caregivers, and the doctors who specialize in these metabolic disorders strongly believe
that a home measurement device would enable significantly improved metabolite control and health
outcomes. Through work in Phase II awards from the National Institutes of Health (R44HD107897) and the
National Science Foundation (2111884), the company has developed demonstrably excellent technology that
enables accurate measurement of the metabolite in a single drop of blood.
This proposal is submitted as a Commercialization Readiness Pilot to perform late stage development
and commercialization activities needed to overcome key software development, hardware manufacturing,
and regulatory challenges necessary to bring the at home product to market.

Public health relevance
PROJECT NARRATIVE The objective of this SB1 work is to complete commercial and regulatory activities to bring an in vitro diagnostic to market for home measurement of a metabolic parameter. In the long term, home use of this device will enable improved care for patients at risk for metabolic decompensation. Improved measurement will enable improve medical outcomes of these vulnerable patients by enabling timely use of known interventions.